Targeting a Unique Enzyme Mechanism in Non-Mammalian Isoprenoid Biosynthesis

DESCRIPTION (provided by applicant): Although antibiotics exist for M. tuberculosis and the malaria parasite, Plasmodium falciparum, the widespread use of anti-microbial agents has, over time, provided a selective growth advantage for more virulent drug-resistant pathogenic strains that are increasingly difficult to treat. To ensure the availability of effective antibiotics in the treatment of life threatening infections, novel antibacterial targets need to be investigated. Isopentenyl pyrophosphate (IPP) and dimethylallyl pyrophosphate (DMAPP) are essential isoprenoid precursors found in all living organisms. Biogenesis of isoprenoids is carried out via the methylerythritol phosphate (MEP) pathway in most human pathogens, including Mycobacterium tuberculosis and the malaria parasite Plasmodium falciparum. The unique MEP pathway to produce isoprenoids is essential in these pathogens and absent in mammals, and therefore represents a potential drug target for the development of new anti-infective agents. 1-Deoxy-D-xylulose 5-phosphate (DXP) synthase catalyzes the first of seven enzymatic steps in the MEP pathway. This thiamin diphosphate (ThDP)-dependent enzyme catalyzes the formation of DXP from D-glyceraldehyde 3-phosphate (GAP) and pyruvate. DXP synthase is a potential drug target, yet there are few reports describing inhibitors of this enzyme. This proposal describes detailed mechanistic studies of E. coli and M. tuberculosis DXP synthase using tryptophan fluorescence to study substrate binding and steady state kinetics. On the basis of our preliminary results suggesting a novel mechanism in this ThDP-dependent enzyme class, we hypothesize that DXP synthase can be selectively inhibited by targeting a conformation that is unique to this enzyme, namely the conformation comprising the catalytically competent ternary complex. The rationale for the proposed studies is that developing strategies for selective inhibition of this enzyme will provide new tools for investigating this essential pathway in pathogens and will lead to new anti-infective agents.

Public health relevance
With the incidence of multidrug resistant bacteria on the rise, there is a need for more effective drugs that require shorter treatment durations, smaller doses, and are more cost effective. In order to achieve these goals, new targets for anti-infective medications need to be examined. The goal of this project is to develop selective inhibitors of an essential enzyme in non-mammalian isoprenoid biosynthesis, DXP synthase, as new agents against infectious diseases, such as drug resistant tuberculosis and malaria.